Intestinal proteases in alcohol-associated liver disease

Project Summary
Alcohol-associated health problems are a major medical burden in industrialized countries. Patients with
alcohol-associated liver disease (ALD) show intestinal dysbiosis and gut barrier dysfunction. Increased
intestinal permeability allows microbe-associated molecular patterns (MAMPs) such as lipopolysaccharides
(LPS) to translocate to the liver and cause progression of ALD. The molecular mechanisms how alcohol
mediates disruption of tight junctions are incompletely understood. Using multiplexed quantitative
proteomics as an unbiased approach, our preliminary results demonstrate that fecal samples from patients
with alcohol-associated hepatitis (AH) contain an increased abundance of host-derived proteases as
compared with healthy controls and patients with alcohol use disorder (AUD). Fecal Cathepsin B (Ctsb)
levels were associated with increased mortality in patients with AH. Our laboratories further demonstrate
that Ctsb is predominantly expressed in macrophages in the intestine and its secretion is upregulated after
chronic ethanol feeding in mice. Fecal supernatant from patients with AH induces barrier disruption in a
Caco2 cell monolayer, which is blocked with the specific Ctsb inhibitor CA-074. This is supported by data
demonstrating that oral administration of the gut-restricted Ctsb inhibitor CA-074 stabilizes the gut barrier
and reduces ethanol-induced liver disease in mice. The testable central hypothesis of this proposed
collaborative and multidisciplinary research application implicates that the ethanol-mediated induction of
Ctsb in intestinal macrophages contributes to gut barrier dysfunction by directly degrading intestinal tight
junction proteins and promoting ALD. Through the proposed studies we will characterize host gut proteases
and the immune response in a human cohort and a mouse model of ethanol-induced liver disease. Towards
this goal, we will characterize human proteases in fecal samples and intestinal biopsies of patients with
ALD. We predict that increased fecal Ctsb correlates with clinical severity and outcome in patients with ALD
(Aim 1). We will mechanistically determine the role of Ctsb in contributing to intestinal tight junction
disruption. We will characterize the source, regulation and substrates of Ctsb using mouse intestinal
macrophages and human intestinal organoids. We will use mice with a myeloid specific deletion of Ctsb and
subject them to chronic-plus binge ethanol feeding (Aim 2). We will use a pharmacological intervention with
an intestine restricted and specific Ctsb inhibitor in a mouse model of ethanol feeding (Aim 3). We believe
these studies will provide important insights into alcohol-mediated changes of intestinal proteases that result
in gut barrier dysfunction and promote ALD. Eventually this approach will lead to new therapeutic targets for
patients with ALD.

Public health relevance
Project Narrative Alcohol-associated liver disease affects several million people in the United States. Gut-derived bacterial products are necessary for progression of alcohol-associated liver disease, but the mechanisms by which alcohol causes the gut to become leaky are poorly understood. We will investigate how intestinal proteases promote alcohol-associated liver disease and will offer innovative therapeutic strategies to prevent or ameliorate these diseases.